Sensory Cross-Activation in Bowel Dysfunction

PROJECT SUMMARY
It is a common occurrence in human that pain is perceived at a remote location away from the diseased
organ. This is also true with bowel dysfunction. Patients with inflammatory bowel diseases (IBD) and/or irritable
bowel syndrome (IBS) often experience bladder hyperactivity and somatic pain. Understanding the peripheral
mechanisms of pain generation and sensory cross-sensitization helps development of therapeutic approaches
with minimum central adverse effects to treat pain comorbidity. Peripheral glial cells are gaining increased
recognition for their roles in modulating sensory neuron activity. Satellite glial cells (SGCs) of dorsal root
ganglia (DRG) reside around sensory neurons and connect sensory neurons through SGC networks. Using
Cre-based expression of hM3Dq to activate glial cells by clozapine-N-oxide (CNO), we show that activation of
glial cells leads to an enhanced calcitonin gene-related peptide (CGRP) release to the spinal cord, an essential
process in spinal central sensitization. Activation of glial cells also facilitates hypersensitivity of the colon,
urinary bladder and hind paw in mice. In DRG, TrkB.T1 is expressed by SGCs but not neurons. Calcium (Ca2+)
activity is a common pathway mediated by hM3Dq and TrkB.T1 in SGCs. Importantly, using a unique SGC-
sensory neuron co-culture system we show that activation of SGCs mediated by TrkB.T1 leads to activation of
adjacent sensory neurons that participate in pain processing. We therefore hypothesize that TrkB.T1 mediates
glia-neuron interaction and participates in sensory neuron cross-activation and cross-organ sensitization. To
test this hypothesis, we will use mice with inducible conditional TrkB.T1 deletion (TrkB.T1cKO) from peripheral
glia mainly from SGCs and mice with hM3Dq or hM4Di expression in peripheral glia. We will perform molecular
and functional analysis of colon-bladder sensory neuron cross-activation and cross-organ sensitization in these
unique mouse lines (Aim 1). The functional roles of TrkB.T1 in SGCs are to increase the levels of Ca2+ to
promote gliotransmitter release. We have identified a number of glial mediators that are regulated by TrkB.T1
in SGCs through proteomic screening and transcriptional analysis. We will characterize TrkB.T1-mediated
gliotransmission and gliotransmitter-facilitated sensory neuron activation in the context of cross-organ
sensitization (Aim 2). Central sensitization not only contributes to colon-bladder cross-sensitization but also
underlies viscero-somatic cross-sensitization. We therefore will examine whether TrkB.T1-mediated SGC-
sensory neuron crosstalk contributes to CGRP central release and leads to viscero-somatic cross-sensitization
(Aim 3). Throughout the three aims, we will use more than one animal models and apply in vivo and in vitro
approaches for functional and mechanistic studies. Interestingly, our preliminary data show that TrkB.T1 is
sexually dimorphic. We therefore will perform our experiments in both genders. We anticipate revealing the
role of TrkB.T1 in glia-neuron interaction to provide insights in understanding the development of cross-organ
sensitization and suggest therapeutic targets.

Public health relevance
PROJECT NARRATIVE Cross-organ sensitization is a common occurrence in patients and animals with bowel dysfunction. Glial cells are important players in sensory neuron sensitization and cross-activation. TrkB.T1 has a specific role in satellite glial cells of dorsal root ganglia to regulate sensory cross-activation and cross-organ sensitization.